ALS Efficiently Networking Advanced Beam Line Experiments (ALS-ENABLE)

Overall Summary/Abstract
The overall goal of this proposal is to continue to provide an integrated, efficient synchrotron structural biology
Resource to the research community. This Resource, called ALS-ENABLE, is located at the Advanced Light
Source (ALS) in Berkeley, California. The team has two decades of experience operating macromolecular X-ray
crystallography (MX) and small angle X-ray scattering (SAXS) beamlines, and more recently, an X-ray
footprinting mass spectrometry (XFMS) beamline. The team has worked closely together over the last 4 years
to create the ALS-ENABLE Resource, and many of the team members are cross-trained in the three X-ray
structural biology methods. During the 4 years we have implemented a transparent interface to the ALS structural
biology resources, and helped users pursue successful structure determination for both routine and challenging
problems. We have worked with a diverse user community, ranging from experts to new synchrotron users with
limited training in structural biology techniques. Where necessary we have guided users through the most
appropriate routes for answering their biological question. In this renewal application we propose to make several
changes to the Resource in response to recent changes in the field of structural biology, leverage a new high-
performance beamline (GEMINI), and incorporate the now mature synchrotron technique of X-ray footprinting
(XFMS).

Public health relevance
Project Narrative - Overall X-ray crystallography, solution scattering and X-ray footprinting are critical tools in the study of biological systems. They provide information that has been a prerequisite to understanding the fundamentals of life. They are also methods that have proved themselves to be central to the development of new therapeutics for human disease. The overarching goal of this proposal is to provide an integrated synchrotron Resource that makes mature technologies available to a broad research community. This will lead to more insightful biological interpretation and better drugs to improve human health.